Long-term Percutaneous Access Device for Home Therapies

DESCRIPTION (provided by applicant): The goal of this proposal is to finalize the development and begin the commercialization of an advanced percutaneous access device (PAD) appropriate for use in chronic home treatment modalities that require long-term body access, such as heart assist devices for treatment of chronic heart failure, total parenteral nutrition, drug delivery, and ambulatory peritoneal dialysis. The PAD is pre-seeded with autologous fibroblasts derived from a small sample of the recipient's skin. Cell seeding improves the device's clinical performance, creating a seal impervious to fluids and microorganisms and minimizing the risk from infection. The purpose of this project is to develop a new PAD, improving upon the first generation ViaDerm TM PAD that demonstrated multiyear stability in animal studies and has been used with excellent results in a series of 9 patients receiving a heart assist device for a total of 1054 patient days. The in vitro results of Phase I demonstrated that fibronectin provided for the best cell retention on the surface of the PAD, however, were insufficient to conclude which of 2 substrates, polycarbonate or polyurethane, provided for optimal protection of the device/tissue interface. The work under this phase II SBIR will focus on: 1) optimizing the device by finalizing the selection of the substrate for the new device, 2) optimizing the cell seeding process by pre-coating the surface with fibronectin and minimizing the overall time required for preparation of the device to make it commercially attractive. The specific aims are to improve the instrumentation and techniques for PAD preparation and to test the device in a series of long-term animal studies. To commercialize this product, the company plans to enter into strategic partnerships with, or license to, major corporations selling supplies to patients in each market. The new PAD is likely to be a premium product, but its cost will be outweighed by benefits of reduced hospitalization, disability and loss of earnings and by improved quality of life.